Relative and intersectional analysis of social determinants of lung cancer risk among Black and Hispanic All of Us respondents

PROJECT SUMMARY
Non-Hispanic (NH) Black adults and Hispanic adults, particularly men, experience significant lung cancer
disparities. Those who are diagnosed with lung cancer tend to be diagnosed at more advanced stages and
have lower survival rates than NH White counterparts. Identifying the factors that explain sex and racial/ethnic
differences in lung cancer risk among NH Black and Hispanic individuals is critical for the development of
tailored interventions that effectively address lung cancer and related disparities in these populations. While
social determinants of health (SDOH) are important factors necessary for understanding minority health and
health disparities, little is known about their relative and combined influence on lung cancer risk. This new
information is key for the development of effective approaches to mitigate lung cancer disparities affecting NH
Black and Hispanic individuals. We propose a theoretically grounded and innovative conceptual model that
examines the relative and combined influence of traditional dimensions of SDOH on lung cancer risk at the
intersection of sex and race/ethnicity among NH Black and Hispanic adults in the US. We will use data
collected as part of the All of Us epidemiological study, a national effort supported by the National Institutes of
Health with the goal of accelerating research and improving health. We will measure lung cancer risk as a
composite score of tobacco use and lung cancer family history. Our aims include cross-sectional examinations
from a large sample of NH Black and Hispanic men and women. First, we will identify the SDOH that, relative
to sociodemographic characteristics, have the strongest associations with lung cancer risk. These analyses will
indicate how specific SDOH may overpower the effect of protective sociodemographic factors, thereby
informing diminished gains from current lung cancer prevention approaches among NH Black and Hispanic
individuals. Second, we will examine how patterns of SDOH inform lung cancer risk among NH Black and
Hispanic adults. These analyses will highlight how unique combinations of SDOH inform sex by race/ethnicity
differences in lung cancer risk among NH Black and Hispanic adults. This study’s findings will advance our
understanding of diminished gains for NH Black and Hispanic individuals from lung cancer prevention
approaches. Further, this study will identify new potential therapeutic targets for clinical and public health
intervention development. Thus, findings from this project will have a sustained and powerful impact on the
field of lung cancer disparities research.

Public health relevance
PROJECT NARRATIVE This project promises to inform public health research by identifying concomitant social determinants of health that uniquely influence sex differences in lung cancer risk among NH Black and Hispanic adults. This work will advance our understanding of diminished gains for Black and Hispanic individuals from lung cancer prevention approaches. The results will identify new potential therapeutic targets for clinical and public health intervention development.